MATHEMATICAL MODELING SYSTEMS

The objective of this project is to acquire, make available, and support mathematical modeling and data analysis software systems that are accessible to investigators from many disciplines. The principals involved develop, test and implement such software on DCRT-supported computing platforms. They develop supplementary software and utilities to optimize the use and efficiency of such software systems. In addition, consultation and training are made available both through formal DCRT-sponsored courses and through individual consultations.